Surveillance Colonoscopy in Older Adults: The SurvOlderAdults Study

Background: Colorectal cancer (CRC) is the 2nd leading cause of cancer death in the US. Screening reduces
incidence and mortality, in part due to detection and removal of polyps such as adenomas. Guidelines
recommend surveillance colonoscopy after adenoma removal (“polypectomy”), but incremental benefit of
surveillance after polypectomy on reducing CRC risk is uncertain. For adults age 75 and older (“older adults”)
considering surveillance colonoscopy, these issues are of particular importance. Harms associated with
colonoscopy increase dramatically with age. Older adults are less likely to live long enough to benefit from
interventions such as surveillance colonoscopy due to competing non-CRC mortality risks. The well-
established age-related increasing risks for competing causes of mortality and colonoscopy-related harms
stand in sharp contrast to major evidence gaps; it is unclear whether CRC risk is clinically significant among
older adults with prior history of polyps, and whether exposing older adults to surveillance reduces CRC risk.
Yet, the default clinical paradigm is for many older adults to receive surveillance colonoscopy. Significance: In
the Department of Veterans Affairs (VA), surveillance is a very common indication for colonoscopy among
older Veterans, with an estimated 17,400 exposed to surveillance annually. The mismatch between available
evidence and current clinical practice, coupled with extreme constraints on colonoscopy resources in the VA
make the surveillance colonoscopy paradigm an ideal focus area for quantifying risks and benefits in order to
optimize health outcomes. Innovation & Impact: Establishing CRC risk among older adults with prior
polypectomy and outcomes associated with surveillance will fill critical evidence gaps. Multi-stakeholder
perspectives on CRC risk and surveillance outcomes will pave the way for future implementation of evidence-
based, Veteran-centric, and optimized-value strategies for surveillance among older adults. This work will also
serve as a model for leveraging VA data to address an important population health challenge for the VA’s large
and growing older adult population and how to use these data to engage Veterans to optimize outcomes.
Specific Aims: Aim 1) Compare cumulative CRC risk after age 75 in a cohort of older adults with history of
normal colonoscopy (n=101,328) vs. colonoscopy with polypectomy (n=29,548) prior to age 75. Hypothesis:
Cumulative risk for incident CRC (primary analysis) and fatal CRC (secondary analysis) after age 75 will be
similar among older adults who had normal colonoscopy vs. colonoscopy with polypectomy prior to age 75.
Aim 2) Assess comparative effectiveness of exposure vs. no exposure to surveillance for reducing CRC risk.
Hypothesis: Older adults unexposed vs. exposed to surveillance will have similar risk for incident CRC (primary
analysis) and fatal CRC (secondary analysis). Aim 3) Obtain multi-level stakeholder perspectives regarding
CRC risk and surveillance outcomes to inform future use and VA policy regarding surveillance colonoscopy in
older Veterans. Methodology: Aim 1 will leverage a previously established colonoscopy cohort to compare
risk for CRC among older adults with prior normal colonoscopy vs. polypectomy. Aim 2 will employ a case-
cohort design to evaluate risk for CRC (cases) among older adults with prior polypectomy subsequently
exposed vs. unexposed to surveillance colonoscopy. Aim 3 will include one-on-one interviews with patients
and providers (Aim 3a) and convening an expert panel of multiple stakeholders (including patients, providers,
and VA policymakers) to review data from Aims 1, 2, and 3a and generate recommendations for surveillance
colonoscopy in older adults that can guide VA policy around surveillance among older adults. Next Steps/
Implementation: Guidelines within and outside VA will be informed by the novel evidence on CRC risk among
older adults with prior polypectomy and impact of exposure to surveillance on CRC risk outcomes, as well as
multi-stakeholder perspectives on how new evidence should inform decision-making and clinical practice.

Public health relevance
Colorectal cancer is a common cancer among Veterans. Screening for colorectal cancer, including through colonoscopy with detection and removal of polyps, can reduce risk for colorectal cancer. Polyps are frequently removed during colonoscopy, with routine recommendations to repeat a colonoscopy to look for new colon growths within 3 to 10 years. Though repeat colonoscopy after polyp removal is commonly done, it is unclear whether this strategy is helpful. This lack of information is especially important for Veterans age 75 and older, because the chances of colonoscopy-related complications increase with age. The goal of this research is to determine whether older adults with a history of polyp removal have increased colorectal cancer risk, whether performing repeat colonoscopy for older adults with prior history of polyps lowers colorectal cancer risk, and to gather perspectives from Veterans and other stakeholders on how this new evidence should inform decisions older Veterans and their care teams make about prioritizing colonoscopy relative to their other health goals.